Regional Medical Library for Region 3 of the Network of the National Library of Medicine (AR, KS, LA, MO, NE, OK, TX) and National Public Health Coordination Office

The Gibson D. Lewis Health Science Library of the University of North Texas Health Science
Center at Fort Worth proposes to host the Regional Medical Library for Region 3 of the Network
of the National Library of Medicine (NNLM) in order to achieve its mission of working through
libraries and other members to support a highly trained workforce for biomedical and health
information resources and data, improve health literacy, and increase health equity through
access to information. Region 3 will serve as a regional hub to develop a highly skilled
workforce, ensure proper stewardship of funds, and develop unique engagement opportunities
for network member libraries and other organizations to carry out regional and national
programs. In partnership with key stakeholders throughout the region, Regional Medical
Libraries (RMLs), NNLM Offices and Centers, and the National Library of Medicine (NLM),
Region 3 will serve audiences that include researchers, health professionals, public health
workforce, educators, and underserved populations in Arkansas, Kansas, Louisiana, Missouri,
Nebraska, Oklahoma, and Texas.
The Overall Specific Aims are to (1) build a learning organization that is responsive to the needs
of the region and collaborative with key stakeholders, other RMLs, NNLM Offices and Centers,
the NNLM Evaluation Center (NEC), and the National Library of Medicine to achieve the
mission and goals of the NNLM; and (2) authentically engage with the community to promote
and build trust in NLM health information, biomedical resources, data, and other products to
reach all communities in collaboration with partners in and out of the region.
In order to achieve these goals in the new performance cycle, Region 3 will focus on continuous
improvement and data-driven practices in collaboration with the NNLM Evaluation Center
(NEC) and the NNLM Training Office (NTO) to ensure it is effectively serving regional needs
through a variety of training approaches, funding opportunities, and programming.
Additionally, it will develop more robust engagement and communication strategies that are
both sustainable and meaningful for growing network membership. Last but not least, the
Regional Medical Library will take a cross-sector approach, recognizing that tackling social
determinants of health such as literacy requires engaging a variety of organizations and partners
to make a lasting impact in our communities.

Public health relevance
Project Narrative Region 3 of the Network of the National Library of Medicine (NNLM), hosted by Gibson D. Lewis Library at the University of North Texas Health Science Center (UNTHSC) in Fort Worth, Texas, will serve the states of Arkansas, Kansas, Louisiana, Missouri, Nebraska, Oklahoma, and Texas. The Regional Medical Library (RML) supports the mission of the NNLM to provide health professionals, the public health workforce, educators, and the public with equal access to biomedical and health information resources and data. The RML will offer diverse trainings, funding mechanisms, and regional and national programming, with a focus on collaboration and continuous assessment to develop a highly-trained workforce and serve as trusted ambassadors between the National Library of Medicine and the communities they serve.